NIAID/USUHS -AFFRI IAA for Animal Model and Drug Development to Treat Radiation Injury

NIAID’s primary focus remains in the areas of infectious diseases and biodefense research for the nation, while AFRRI’s primary interest is centered on hazards associated with ionizing radiation with particular emphasis on the military population. It has long been recognized that medical products developed for the military may have direct applicability in civilian settings. With this in mind and with a commitment of both organizations and the DoD and HHS to develop the best and most effective medical countermeasures against radiological threats to the nation, a spirit of partnership has developed between the Parties to initiate synergistic research endeavors. The development of safe and effective radiological medical countermeasures remains a high priority in national preparedness, and research achievements in the area of medical radiobiological research have applicability to medical biodefense. For example, exposure to ionizing radiation results in the disruption of cellular immune functions which leads to increased susceptibility to agents of bioterrorism, as well as infectious diseases.